Dermatology Training Grant

The Harvard Medical School Department of Dermatology T32 training grant has been active for more than 45
years, and over that period of time has trained many postdoctoral fellows who have become national leaders
in dermatology. Dr. Thomas Kupper has served as Principal Investigator since 2000. There are three
Harvard-appointing Dermatology departments: the Beth Israel Deaconess Hospital, Brigham and Women's
Hospital, and Massachusetts General Hospital. An executive committee comprised of the chairs of these
departments oversees the Harvard combined residency program, and provides advice and counsel to Dr.
Kupper with regard to the T32 grant. The training grant has two overarching goals. The first is to identify,
recruit, and support promising dermatologist physician scientists interested in a career in biomedical
research. While such candidates most often come from Harvard's Dermatology Residency program, trainees
from other dermatology residencies are eligible as well. The second goal is to support the development of
outstanding PhD scientists who are interested in a research career in investigative dermatology and related
fields. Considering the past decade of the training grant, all 30 of our trainees continue to be involved with
biomedical research, whether in academic medicine or biotechnology/pharmaceutical companies. This group
of 30 trainees has authored 173 peer-reviewed manuscripts over the past decade, with a mean impact factor of
7.9. Over the past decade, T32 graduates have successfully competed for extramural funding as PI's, including
National Institutes of Health K23, K12, K08, and DP5 awards (from the Office of the NIH Director); applications
for K99/R00 and K08 grants are pending. For the next funding cycle, we have retained our External Advisory
Board consisting of eminent academic dermatologists and scientists who will assist with choosing candidates
and evaluating progress. It remains our conviction that Training Grant support for biomedical scientist
postdoctoral fellows interested in skin disease research has never been more critical to their careers, and by
extension, the long-term survival of academic investigative dermatology.

Public health relevance
Project Narrative At least two years of mentorship and training in research approaches and techniques are absolutely essential as graduates of dermatology training programs or PhD programs transition from student to independent biomedical scientists. The Harvard Dermatology Training grant provides this support, partnering the most promising trainees with accomplished and supportive research mentors who will sponsor their work in their laboratories. We wish to continue to build on the extraordinary success that this program has achieved over the last 45 years, in training the best and the brightest biomedical scientists of tomorrow.